Laser Scanning Imaging System in Support of Single-Molecule Studies of Genome Integrity

PROJECT SUMMARY
Our chromosomes are constantly bombarded with a variety of insults, resulting in damage that must be repaired.
Cells have evolved mechanisms to detect and repair broken strands of DNA, thereby preventing loss of important
genetic information. Double-stranded DNA breaks (DSBs) are a type of damage that lead to particularly
disastrous outcomes. If not corrected, DSBs can cause gross chromosomal rearrangements, which are the
hallmark of all forms of cancer.
Homologous recombination (HR) is a conserved pathway that cells can use to repair DSBs, and HR is necessary
to prevent and repair the damage that arises during DNA replication. When a DSB occurs, the DNA ends are
processed to generate 3’ single-strand DNA (ssDNA) overhangs. The ssDNA ends then pair with homologous
sequence elsewhere in the genome, and the missing DNA is replaced using the homologous DNA as a template
for replication. Finally, the replicated intermediate is resolved, regenerating the continuity of the broken DNA. HR
requires the coordinated action of a complex repertoire of proteins, which are responsible for sensing damage,
recruiting essential factors, and processing and repairing the damaged DNA. The consequences of disrupting
HR are devastating. For example, mutations in the RAD51 recombinase are embryonic lethal in mice, and
mutations in human RAD51 are linked to breast cancers. In addition, defects in BRCA2 account for at least 5%
of all breast cancers and also confer a genetic predisposition to ovarian cancer. BRCA2 is thought to help
regulate HR, and loss of this regulation may be the reason why this gene is linked to hereditary cancers. New
discoveries will be necessary to fully understand the mechanistic basis for these outcomes.
Our research program is focused on understanding how proteins sense and respond to damaged DNA and they
then repair the damaged DNA to prevent mutations that can lead to cancer. To help address these problems we
have developed unique technologies that allow us to directly visualize hundreds of individual molecules using
optical microscopy, which enables us to monitor the spatial and temporal progression of DNA repair and DNA
replication in real-time at the single-molecule level. Using this approach, we seek to define the fundamental
mechanisms that our cells use to replicate and repair DNA, with the long-term goal of understanding how errors
during these processes can lead to chromosomal rearrangements.

Public health relevance
PROJECT NARRATIVE Double-stranded DNA breaks (DSBs) can cause gross chromosomal rearrangements, which are the hallmark of all forms of cancer. The overall goal of our research is to study the events that lead to DSB formation and the mechanisms that cells use for DSB repair, in the hope that this research will eventually lead to a better understanding of how might be able to prevent or cure cancer.